Hormones and Mechanotherapeutics: Restoring Altered Hyaluronan Biology in Mucosal Wound Healing Using Vaginal Tissue as a Model

Project Summary/Abstract
The high incidence of post-surgical fibrosis is no trivial feat for a pediatric gynecologist such as myself who is
among the the few specialists trained to perform intricate vaginal reconstruction surgeries. What is strikingly
perplexing is that, unlike dermal tissues, oral, gastrointestinal, and vaginal mucosa are programmed to heal
regeneratively and without scarring. Yet, there are no scientifically tailored clinical strategies to prevent or at
least treat vaginal fibrosis, which currently rely on the application of tissue stretch with rudimentary dilators or
stents and local treatment with pre- and post-operative estrogen. The inevitable result is high morbidity,
increased health care costs, and significant reduction in quality of life for adolescent and adult female patients
that had just endured the trauma of vaginal surgery, injury, or pelvic radiation. I plan to use this K08 award to
develop myself as one of a few pediatric gynecological surgeon-scientists and use this platform to understand
what directs vaginal mucosal tissue into regenerative or fibrotic repair. While I acknowledge the gap of
knowledge, I also recognize that the key to decipher the dichotomy of tissue regeneration and fibrosis lies with
the ubiquitous extracellular matrix (ECM) signaling, particularly through proteoglycans such as hyaluronan via
a specific receptor. In particular, hyaluronan (HA) is known to impact wound healing through its high affinity
receptor CD44, where the latter engages in inflammatory reactions upon HA binding. Remarkably, pro-
inflammatory low and anti-inflammatory high molecular weight (LMW/HMW) HA variants are synthesized upon
injury, which led me to query whether estrogen levels play any role to modulate how ECM directs HA/CD44
signaling in the vaginal mucosa. Notably, my preliminary data show that fibrosis can be attenuated by
combined estrogen and hyaluronan (HA) controlled release delivery, where the combined protective effect
against fibrosis was upheld by enhanced anti-inflammatory and pro-angiogenic reactions. Through testing of
stents with different material properties, these studies also unveiled a critical threshold of tissue stretch that
contributes to regenerative repair and suggest that HA and estrogen are essential mediators of these effects.
However, the missing link is that the mechanisms that transduce estrogen-driven HA/CD44 signaling to direct
mucosal repair remain unknown. Hence, my overarching hypothesis is that the direction of vaginal wound
repair is governed by estrogen-driven signals transduced via HA ligand/CD44 receptor interactions that
respond to tension. Thus, I aim to: (i) Investigate the role of estrogen on the regulation of HA biology in vaginal
tissue repair; (ii) Study how estrogen drives CD44 signaling-mediated vaginal inflammation and influences
regenerative tissue repair; and (iii) Test whether regulating the estrogen-HA-axis can improve wound repair. At
the end of this K08 award, I will have acquired the necessary skills and knowledge to become an independent
investigator, pursue a career as a surgeon-scientist, and lead the field of mucosal regeneration.

Public health relevance
PROJECT NARRATIVE Vaginal scar tissue is a debilitating occurrence, commonly associated with reconstructive surgery, trauma, or pelvic radiation for cancer, that can have life-long sequelae. Unfortunately, there are limited means of preventing or treating vaginal fibrosis due to the paucity of knowledge about how mucosal tissues, and vaginal tissues specifically, heal and respond to common clinical interventions such as dilation or hormone therapy. This project seeks to be the first to understand the mechanisms behind vaginal wound healing and will test our central hypothesis that biomechanical forces and hyaluronan impact estrogen's role in promoting mucosal homeostasis, which will generate a framework for the development of tailored anti-fibrotic therapies.